A brief alcohol intervention to reduce alcohol use and improve PrEP ouctomes among men who have sex with men: A randomized controlled trial in Vietnam

PROJECT SUMMARY
Unhealthy alcohol use is common among men who have sex with men (MSM). Unhealthy alcohol use is a
spectrum from risky/hazardous drinking to alcohol use disorder. For MSM, unhealthy alcohol use may reduce
PrEP persistence and adherence, which are critical for HIV prevention. Reducing unhealthy alcohol use may
improve PrEP outcomes. The brief alcohol intervention (BAI), which draws on Motivational Interviewing and
Cognitive Behavioral Therapy, increases viral suppression among people living with HIV on antiretroviral
therapy. This effect is mediated through increased adherence. The BAI may have a similar effect on PrEP
outcomes among MSM with unhealthy alcohol use. We propose an effectiveness-implementation type 1 hybrid
randomized controlled trial (RCT) to compare the BAI to standard of care among MSM with unhealthy alcohol
use initiating or re-initiating PrEP in Vietnam. We hypothesize that the BAI will improve a) PrEP persistence, b)
PrEP adherence, and c) risk-aligned PrEP use (PrEP use consistent with current risk, including event-driven
PrEP). Our specific aims are to: 1) Assess effectiveness of the BAI for increasing PrEP persistence and
adherence among MSM in Vietnam; 2) Assess the impact of the BAI on alcohol use among MSM; 3) Estimate
the cost-effectiveness, feasibility, and acceptability of scaling up the BAI in PrEP clinics throughout Vietnam.
The trial and intervention will be conducted at the Hanoi Medical University PrEP clinic for MSM Vietnam.
Evaluation visits will be conducted at UNC Project-Vietnam. Eligible participants will include MSM (n=506)
presenting to the PrEP clinic for PrEP initiation or re-initiation after 6 months without PrEP. The participants
must also screen positive for unhealthy alcohol use with an AUDIT-C score ≥ 4. After baseline evaluations,
participants will be randomized to either standard of care or the BAI, which comprises two in-person and two
telephone visits. Each participant will be followed quarterly with interviews, including use of timeline followback
to elicit PrEP use, alcohol use, and sexual behavior, and tests for HIV infection, gonorrhea, chlamydial
infection, and syphilis. Alcohol use and PrEP adherence will also be assessed with biomarkers. The primary
effectiveness outcome is PrEP persistence at 6 and 12 months. Secondary outcomes include PrEP adherence,
assessed by self-report, pharmacy records, and validated bioassays; risk-aligned PrEP use; and alcohol
outcomes (heavy drinking days (binge drinking), defined as the number of days with ≥5 drinks per occasion;
number of drinking days; and drinks per drinking day; and phosphatidylethanol level). The primary
implementation outcomes are the incremental cost-effectiveness ratio, expressed as the incremental cost per
quality-adjusted life-year gained, and feasibility and acceptability. If successful, this study will be set to ensure
rapid scale up of an intervention to improve the lives of MSM by reducing unhealthy alcohol use and increasing
PrEP use for HIV prevention.

Public health relevance
PROJECT NARRATIVE When men who have sex with men use alcohol excessively, they experience greater risk of HIV infection; they may also have reduced adherence to and less retention in pre-exposure prophylaxis (PrEP) programs. A brief alcohol intervention, provided over about six weeks, may substantially reduce alcohol use among men who have sex with men. This trial will be conducted in Vietnam to assess the impact of the brief alcohol intervention on retention in a PrEP program and adherence to PrEP.